The Effects of Prenatal Thirdhand E-cigarette Exposure on Platelets

While smoking has been on the decline, Electronic Delivery Systems (ENDS) usage has been on the rise;
especially in vulnerable populations. Furthermore, even though the contribution of in utero third-hand smoke
(THS) and e-cigarettes to the pathogenesis of thrombotic diseases have recently been documented, the
involvement of prenatal third-hand e-hookah (another form of ENDS) in such disease processes remains
unknown. Consequently, the present application outlines studies that address fundamental, mechanistic, and
clinically-relevant translational aspects of the adverse-health effects of prenatal thirdhand e-hookah, in the
context of thrombotic disease and platelet biology, and in a sex-specific manner. These studies are of paramount
significance given the “perceived safety” of e-hookahs. The Aims of this proposal are:
Aim 1. Investigate the impact of prenatal thirdhand e-hookah exposure on platelet-dependent disease
states. While there is compelling evidence that e-cigarettes and in utero thrdhand smoke from traditional
cigarettes (THS) do exert negative health effects, the impact of prenatal thirdhand e-hookah on platelet-
dependent diseases is still unknown. To address this issue, the consequences of prenatal thirdhand e-hookah
exposure on normal hemostasis and platelet counts will be determined. Subsequent studies will examine
whether it participates in the development of thrombosis-based disease, and exerts effects on a plasma “marker”
of thrombosis. Notably, experiments will be designed in a manner that addresses the role of sex in mediating the
“platelet”-dependent negative effects of prenatal thirdhand e-hookah.
Aim 2. Investigate the mechanism by which prenatal thirdhand e-hookah exposure modulates platelet
function. Even though published data indicate that in utero THS and e-cigarettes modulate platelet activation,
whether prenatal thirdhand e-hookah produces similar effects (i.e., the mechanism by which it modulates platelet
function) remains to be investigated. Thus, the overall goal of the mechanistic experiments proposed in this
section is to determine the impact of prenatal thirdhand e-hookah exposure on the various platelet functional
responses (e.g., GPIIb-IIIa activation) and biochemical “markers” of platelet activation.
Collectively, these experiments will make significant contributions to the understanding of the
consequences of prenatal thirdhand e-hookah/e-hookah on platelet activation and cardiovascular
human health, and the mechanism by/through which it exerts these effects, in a sex-specific manner.

Public health relevance
Collectively, the experiments presented in this supplemental funding request, and the training plan are designed to develop a minority predoctoral fellow, namely Ms. Precious Badejo as a future scientist. The studies, some of which are translational in nature, address fundamental and mechanistic concerns regarding the prenatal cardiovascular health effects of the novel tobacco product e-hookah under thirdhand exposure conditions, by employing a systematic platelet function and related animal model and disease analysis approach. The training and the results obtained should develop her critical thinking and scientific writing skills, as well as promote further smoking cessation, as well as lay down the foundation for understanding, and advancing policy and means for evidence-based therapeutic management, prevention and control efforts of tobacco-associated thrombosis-based disease states.